METABOLIC &FUNCTIONAL EFFECTS OF FREE RADICALS IN HEART

This project has been restructured with Dr. John Jones as the primary investigator. Several pathophysiological conditions are linked to oxidative stress in the heart including reperfusion injury. Endogenous reduced glutathione (GSH) is a key intracellular antioxidant whose levels are maintained by a NADPH-dependent redox cycle. During oxidative stress both the glutathione redox cycle and NADPH production are activated to maintain optimal GSH levels. In many tissues, NADPH production is boosted by increasing flux through the pentose phosphate shunt. However, the capacity of this pathway in the heart is too low for significant NADPH production. In contrast, the activity of the NADP+-malic enzyme is high, and flux through this enzyme can be readily manipulated by stimulation of selected anaplerotic pathways. The provision of specific exogenous anaplerotic substrates during oxidative stress can alter the extent and direction of flux through the NADP+-malic enzyme which in turn can alter the levels of endogenous GSH. This may modify the susceptibility of the myocardium to oxidative injury. Flux through the NADP+-malic enzyme will be manipulated by supplementing an acetate-perfused heart with two different anaplerotic substrates, pyruvate and propionate. In the normoxic perfused rat heart supplied with exogenous pyruvate, reductive carboxylation by the NADP+-malic enzyme is responsible for the bulk of anaplerotic pyruvate utilization, hence NADPH is consumed under these conditions. In contrast, when propionate is supplied as the anaplerotic substrate, NADP+-malic enzyme flux is reversed and NADPH is generated since the influx of propionate carbons and CO2 into succinyl-CoA is balanced by the oxidative decarboxylation of malate to pyruvate. In the perfused heart, both exogenous pyruvate and propionate induce anaplerotic fluxes that are a significant fraction of the total citric acid cycle flux, hence the capacity for NADPH production or consumption by the NADP+-malic enzyme is also significant. 13C Isotopomer analysis and oxygen consumption measurements will be used to obtain absolute anaplerotic utilization rates of propionate and pyruvate, allowing absolute flux through the NADP+-malic enzyme to be evaluated. Oxidative stress will be generated in our perfused hearts using two simple and well-characterized models; exogenous hydrogen peroxide (H2O2) and exogenous tert-butylhydroperoxide. Myocardial function and viability will be further assessed by contractility measurements, and in situ determination of intracellular pH and phosphate metabolites by 31P NMR spectroscopy.